Administrative, Biostatistics, Data Management, and Bioinformatics Core

Summary
The Administrative, Biostatistics, Data Management & Bioinformatics Core is essential for the smooth
functioning of the overall Program Project. Core A has three major functions: First, the Core will provide
supervision of program finances, administrative and secretarial support, maintenance of authorizations and
adherence to institutional requirements, and coordination of meetings of the Program Project team and the
Internal and External Advisory Boards. Second, the Core will provide data management and Biostatistics support
for the Program Project. Third, the Core will provide Bioinformatics support for the Program Project. All
components of this Core will serve each of the three Projects over all five years of the Program Project.